Development and Initial Trial of Brief Interventions to Help Parents of Stigmatized Youth Reduce Distress and Strengthen Attachment

PROJECT SUMMARY
Parental support represents the strongest predictor of sexual and gender minority youth's (SGMY) mental
health. However, over half of parents react to their SGMY's disclosure with rejection. Even relatively accepting
parents can experience discomfort, while SGMY often report lingering unmet needs from their parents into
adulthood. Few interventions exist to help parents support their SGMY child and none has been tested in a
randomized trial with efficacy for decreasing parental rejection and increasing support of their SGMY. This
proposal will develop and test the efficacy of two theory-based interventions that aim to address this gap.
These interventions respectively address two mechanisms shown to underlie parental rejection of SGMY –
parents' unresolved negative emotions toward their SGMY and lack of empathy toward their SGMY. The first
intervention – expressive writing (EW) – reduces negative emotions by helping people make sense of stressful
events. In our adapted EW, we will ask non-accepting parents to write about the stressful impact that their
child's SGM identity has on them across three 20-min sessions. The second intervention – attachment-based
writing (ABW) – will be based on the only known intervention (called attachment-based family therapy) that
builds empathy among parents of SGMY. However, the parent-focused tasks of attachment-based family
therapy currently require 2-3 sessions with a trained therapist, preventing broad access. We will thus create a
writing-based version of this therapy in a parallel format to EW (i.e., 3 20-min writing sessions). This adaptation
will ask parents to engage with the core components of attachment-based family therapy in writing (i.e., writing
about one's impact on their child, one's own attachment needs, and their child's needs). Across three aims, we
will develop and test the preliminary efficacy of these two brief interventions for non-accepting parents in the
Southeast US – a region with the highest anti-SGM stigma and highest SGMY mental health needs in the US.
Aim 1 will engage community stakeholders, non-accepting parents, and SGMY in the Southeast to inform the
writing prompts and look-and-feel of the online platform. Aim 2 will test the preliminary efficacy of EW and
ABW. We will randomize 129 non-accepting parents to EW, ABW, or control. Parents will report primary
outcomes (i.e., rejecting and supporting behaviors), target mediators (i.e., negative emotions, empathy), and
secondary outcomes (e.g., parent and youth depression/anxiety) at baseline, post-intervention, and 3-month
follow-up. We will also explore the feasibility of asking parents to enroll their child so that we can study the
interventions' impact on SGMY themselves. Aim 3 will determine intervention acceptability and implementation
facilitators in parent support organizations in the Southeast US. Results
to
mental
will identify mechanisms contributing
parental rejection and develop scalable approaches to reduce these mechanisms to shrink the substantial
health disparities affecting SGMY. If efficacious, these interventions can be scaled up through online
platforms capable of bypassing barriers to parental support of SGMY across high-stigma regions.

Public health relevance
PROJECT NARRATIVE Parental support serves as the most robust predictor of sexual and gender minority youth (SGMY) mental health, yet no intervention has shown efficacy for building this support among non-accepting parents. Drawing on deep community engagement and theory and research in psychological science, this project will develop and test the preliminary efficacy of two highly scalable brief interventions capable of building support and reducing rejection among non-accepting parents of SGMY in the Southeast US. Results of this study will identify theoretical mechanisms and scalable interventions capable of improving this important source of SGMY mental health in high-stigma regions.